Presenilin1/gamma-secretase regulate the VEGFA/VEGFR2 brain angiogenesis inhibited by FAD mutants.

Summary
The cerebrovascular system is central to neuronal survival and function and recent evidence suggests that
vascular brain abnormalities are involved in the development and neuropathophysiology of
neurodegenerative disorders such as Alzheimer disease (AD). Angiogenesis, the generation of new blood
vessels from existing vasculature, is crucial throughout adult life for maintaining brain blood circulation and
for reparative mechanisms of toxic insults such as ischemia and hypoxia. Angiogenesis is controlled by growth
factors including the Vascular Endothelial Growth Factors (VEGFs). By binding to their receptors (VEGFRs),
VEGFs regulate formation of new blood vessels and maintain blood supply to tissues and organs. Mutants of
the protein Presenilin1 (PS1) cause Familial AD (FAD) constituting a system where mechanisms of AD-like
neurodegeneration can be studied. A normal function of PS1 is to act as a protease, called γ-secretase, which
processes type I membrane receptors.
Here we present evidence that the PS1/γ-secretase system processes VEGFR2 that is known to play crucial
roles in the regulation of the vascular system, including the brain vasculature. Critical angiogenic functions of
VEGFR2 include its dimerization, internalization and downstream angiogenic signaling of endothelial cells
(ECs). We also found that inhibition of the γ-secretase activity decreases the VEGFA-induced dimerization
of VEGFR2 and the VEGFR2-mediated angiogenenic functions of primary cortical ECs (pCECs) such as
sprouting, tube formation, cell migration and angiogenic complex formation. Together, our data suggest that
γ-secretase regulates the VEGFA-stimulated angiogenic functions of VEGFR2. Importantly, we found that
PS1 FAD mutants decrease the VEGFA-induced γ-secretase processing and dimerization of VEGFR2 and
the VEGFA-stimulated angiogenic signaling and functions of ECs. Together, our data indicate that PS1 FAD
mutants attenuate the VEGFA-induced angiogenic functions of brain ECs suggesting a mechanism by which
FAD mutants cause neuronal dysfunction and death by decreasing angiogenic functions and tissue repair of
the brain. In this application, we explore the interactions of PS1 and its FAD mutants with VEGFR2 and
explore the importance of this interaction to the VEGFA-induced and VEGFR2-mediated angiogenenic
signaling and functions of the brain. We also use mouse models to examine mechanisms by which γ-secretase activity regulates angiogenic signaling of the VEGFA/VEGFR2 system, and test the roles of PS1
and PS1FAD mutants in the VEGFA- and ischemia-stimulated brain angiogenesis. We also explore
signatures of angiogenic dysfunction in human FAD and sporadic AD brain tissue.

Public health relevance
Narrative The brain vascular system is central to neuronal survival and function and it has been suggested that vascular brain abnormalities contribute to the development of Alzheimer disease (AD). Angiogenesis, the generation of new blood vessels from preexisting ones, is crucial to maintaining neuronal health and function and for repairing vascular damage in adult life. We found that genetic mutants that cause familial AD (FAD) target angiogenic functions of the brain, a process that may lead to neuronal damage and dementia. This proposal explores vascular brain mechanisms targeted by FAD mutants and examines effects on neuronal dysfunction and AD. A better understanding of involved mechanisms may indicate new therapeutic approaches to AD.